Bridging the Gap Between Prediction and Reality in Structural Biology

Project Summary/Abstract
My research is about creating the tools, insights and capabilities needed by the field of structural biology to
understand structure-function relationships, including catalysis, enzyme-substrate interactions, and structure-
based drug design. In the next five years this field will face new challenges as accurate structure prediction
generates a firehose of testable hypotheses, shifting the focus of experimental efforts to the “last Angstrom”
between predicted and actual atomic positions. This short distance is where the puzzle pieces of biology and
chemistry fit snugly together, and it is the details on this scale that are vital to understanding the structure-
function relationship. The experiments of the near future must reveal accurate, high-resolution, and damage-
free 3D images. Remarkably, the data used to train current prediction models already contain yet-to-be-
unlocked information. Single-electron changes can be visible in Macromolecular Crystallography (MX) data at
resolutions as low as 3.1 Å, but structural models must be far more accurate to reveal such features. To enable
this robust interpretation of experimental data, I will develop simulation-based models that are minimally
restrained but still faithfully reproduce observed average-image and diffuse-scatter data. These improved,
multi-conformational models will enhance understanding of how macromolecules transmit forces through their
interior and how they influence and interact with other molecules. Deducing these intramolecular
communication networks requires solving the topological problem of simultaneously satisfying observed
density and prior knowledge of chemical geometry. Solving this problem will be made easier by comparing
related structures. This will arise from current technologies for correction of non-isomorphism in real space,
which I will migrate into reciprocal space, enabling merging of incomplete data such as XFEL stills and
parametric structure frameworks. These low-dimensional frameworks will allow selection from a continuum of
3D molecular structures like a marionette by dialing in desired parameter values, such as temperature, pH, or
other reaction progressions. I will test these framework models against the thousands of non-isomorphous data
sets collected at my beamline and report on best practice. Radiation damage will be the final barrier, so to
move towards damage-free data from a synchrotron, we will implement a new kind of data collection called
"painting with X-rays," leveraging modern fast-framing detectors and small X-ray beams to extract the full
information content from each sample and extend zero-dose extrapolation to the single-photon level.
Collectively, I expect the benefits of bridging the gap between prediction and reality to be transformative to
both methods development and functional studies using complementary structural techniques, such as
CryoEM, SAXS, tomography electron diffraction, and especially hybrid methods that combine structural data
from multiple sources.

Public health relevance
Project Narrative Building upon recent advances in structure prediction and determination, we will create advanced tools for simulation, analysis and data collection to meet the challenges of answering the novel questions that connect what our models currently predict and what they do not: understanding of mechanism of biological function.